Developmental Research Program

The objective of the University of Chicago Breast Cancer SPORE Developmental Research Program[unreadable] (DRP) is to create a streamlined and transparent mechanism for soliciting and selecting exciting and[unreadable] novel research projects that have significant potential for translational success. Such projects may be[unreadable] collaborative among scientists within our SPORE, or have collaborations outside the SPORE[unreadable] environment, but must be innovative, potentially high impact, and preferably multi-disciplinary. This[unreadable] program will be led by Dr. Geoffrey Greene, a leader in the estrogen receptor field with a strong interest[unreadable] in translating basic science to clinical breast cancer, and Dr. Suzanne Conzen, a physician-scientist and[unreadable] medical oncologist specializing in breast cancer whose laboratory uses large scale genomic approaches[unreadable] to identify novel anti-apoptotic signaling pathways contributing to the transformation of breast epithelial[unreadable] cells. Specifically, the SPORE DRP will 1) establish a mechanism for soliciting DRP applications that[unreadable] reaches beyond cancer center members and the local SPORE community to all biological, physical,[unreadable] computer and social science faculty members at the University of Chicago and Argonne National[unreadable] Laboratory, as well as to investigators at other SPOREs nationwide; 2) encourage, support, and nurture[unreadable] interdisciplinary collaboration using the expertise of our interdisciplinary Internal Scientific Advisory[unreadable] Committee; 3) select and assess projects that help generate new hypotheses for development as full-fledged[unreadable] SPORE projects.